Atypical MAP Kinase Signal Transduction

Project Summary:
MAP kinases (MAPKs) are regulatory components of many signal transduction
pathways that impact eukaryotic cell growth, differentiation, and movement. Relatively
little is known about the function and regulation of atypical MAPKs (represented by
MAPK15/Erk8 in mammals) found only in eukaryotes that have cell motility. Atypical
MAPKs are not activated by conventional MAPK kinases and the external signals that
trigger activation are not known except in the amoeba Dictyostelium, a model organism
for chemotactic movement and development. We have found that the Dictyostelium
atypical MAPK, Erk2, is essential for chemotactic movement to multiple signals. In our
previously funded research we also discovered that Erk2 phosphorylates specific
residues of a GATA transcription factor, GtaC, resulting in the translocation of this factor
from the nucleus to the cytoplasm in response to at least two chemotactic signals that
promote different cell fates. We have also demonstrated that Erk2 kinase activity is not
required for activation in vivo indicating that an unconventional MAPK kinase regulates
atypical MAPKs rather than autophosphorylation. The proposed research will
investigate if Erk2 promotes different cell fates through the differentially modification of
GtaC or through the regulation of other transcription factors. We will use a GFP tagged
GtaC to map Erk2 docking sites and compare these to docking sites of other groups of
MAPKs. We will also use co-immunoprecipitations, mass spectrometry, and genetic
analysis to identify proteins that associate and function with Erk2 in signaling pathways
and identify proteins that directly regulate Erk2 activation. The results of this project are
expected to identify specific mechanisms of atypical MAPK regulation and function and
uncover roles for atypical MAPK signaling in chemotactic movement and cell fate
determination that can guide the research of MAPKs in other organisms such as
mammals.

Public health relevance
Project Narrative: Atypical MAP kinases (MAPKs) are important components of eukaryotic signal transduction pathways but relatively little is known about the regulation and function of these kinases compared to typical MAPKs. Recent studies have shown that the atypical MAPK in the model organism Dictyostelium is required for chemotaxis and the translocation of a key developmental transcription factor. This project will characterize atypical MAPK regulation and function in chemotactic responses, transcription factor regulation, and cell fate regulation.